Multidisciplinary Research Training in Pediatric Pulmonary Vascular Disease

PROJECT SUMMARY/ABSTRACT
Pulmonary vascular disease (PVD) is a significant source of morbidity and mortality in neonates, infants and
children with diverse heart, lung and systemic diseases. A major barrier to improving outcomes of children with
PVD is the fundamental lack of understanding the differing pathobiologies among the spectrum of these
disorders, which intersect between multiple clinical disciplines. This is compounded by the scarcity of training
opportunities to develop and retain physician-scientists and scientists with expertise in PVD that allows for the
successful translation of laboratory and clinical science across multiple disciplines. Thus, there is a need for
well-trained scientists in Pediatric PVD who can perform collaborative and rigorous inter-disciplinary investigation
to enhance the development of new treatment modalities. This novel application requests the resources to
establish a unique two-year post-doctoral collaborative research training program in Pediatric PVD within the
Departments of Pediatrics at the University of California, San Francisco, the University of Colorado, and
Vanderbilt University. The goal of the program is to increase the number of highly trained, successfully funded
and sustainable pediatric pulmonary vascular scientists, who will perform high level laboratory, clinical-
translational, and/or health services research that will ultimately improve our understanding of the pathobiology of
diverse pediatric PVD, design therapeutic plans that specifically target an individual’s underlying pathobiology,
and thereby improve both short and long-term outcomes. To this end, this program aims to provide comprehensive
scientific training through novel mentoring and collaborative approaches to enhance career development for
physicians or post-doctorate scientists with an M.D., M.D./Ph.D. or Ph.D., who commit themselves to an
academic career in pediatric PVD. The key and unique elements of this training program are: (1) a rich, diverse,
mentored research experience; (2) interdisciplinary and inter-institutional experiences, including joint didactic
learning opportunities, with direct integration into the North American Pediatric Pulmonary Hypertension Network
and the associated Annual International Conference; and (3) continuous review and evaluation from academic
leaders in the field. The centerpiece of the program for pediatric-scientists is the continuation of a 4-year fellowship
training program (including but not limited to Pediatric Cardiology, Critical Care, Emergency Medicine,
Neonatology, or Pulmonology), with 2 years devoted to intense research training in basic laboratory science,
clinical-translational science, health services or epidemiology related to pediatric PVD. Exceptional faculty have
committed their support as mentors, who lead and are affiliated with several of their universities’ research units
and clinical programs, a represent a “critical mass” that few single centers can provide. Thus, the rationale for this
novel proposal is based on the need for well-designed training programs in Pediatric PVD research, including
the need to foster multi-disciplinary and multi-interdisciplinary collaborative approaches, and that these three
institutions have the vision, experience, and collaborative infrastructure to train the next generation of leaders.

Public health relevance
PROJECT NARRATIVE The needs for skilled academic physician-scientists in Pediatric Pulmonary Vascular Disease and multi- institutional, collaborative and rigorous investigation of new treatment modalities with focus on pathobiology and long-term outcomes are clear. The goal of the training program is to increase the number of highly-trained, successfully-funded and sustainable pediatric pulmonary vascular disease physician-scientists, who will perform high level laboratory, clinical-translational research, and/or health services research that will improve our understanding of the pathobiology of pediatric pulmonary vascular disease, and thereby improve short and long- term outcomes for this complex, vulnerable population. This training program uniquely leverages existing collaborative, multicenter and interdisciplinary academic programs as critical infrastructure that will provide outstanding training opportunities for career development in the field.